Novel technologies for cellular age profiling and validation

Project Summary
Objective. This project aims to address a critical challenge in biomedical research – the reliable identification of
cell line age and division/passage history. Leveraging recent advances in synthetic biology and genome editing,
we propose the development of an innovative technology using genetic PUFs, a novel concept inspired by the
semiconductor industry, for precise quantification of cellular age. Our technology is expected to significantly
enhance the reproducibility and reliability of experimental outcomes in biomedical research.
Today there are no commercially available methods to calculate and attest cellular age. Methods such as
simple passage tracking are not standardized across labs and can be prone to errors or mislabeling. Moreover,
STR profiling, while effective for confirming cell line identity (but not clonality), does not provide information about
passage history or genomic drift that arise from aging.
Specific Aims:
Development of Genetic PUFs. Utilizing a combination of molecular barcoding and CRISPR-induced DNA
repair mechanisms, we will embed unique, robust, and unclonable genetic identifiers within cell lines. This will
allow for accurate tracking of cell line provenance and age, ensuring the integrity of biomedical experiments.
Establishing a Cellular Clock. By characterizing the temporal drift space of genetic PUFs and employing
advanced machine learning algorithms, we will develop a "cellular clock". This clock will provide a standardized
method to monitor and record critical cellular events and divisions, thereby accurately determining the biological
age of cell lines.
Health Relatedness. The proposed technology directly addresses the pervasive issue of cell line
misidentification and contamination in biomedical research. By ensuring the authenticity and age of cell lines,
our innovation will contribute to more accurate and reliable research outcomes, ultimately benefiting health-
related studies and pharmaceutical developments.
Research Design and Methods. Our approach integrates cutting-edge genome editing techniques and
computational methodologies. Our first aim will focus on the creation and characterization of genetic PUFs in a
variety of cell lines over multiple divisions/passages. Our second aim will extend these findings to develop a
comprehensive platform for cellular age identification, integrating machine learning models for predicting and
validating the age of PUFed cell lines. We will conduct rigorous testing and validation across different cell lines
and conditions to ensure the robustness and applicability of our technology.
Impact. The successful completion of the proposed work will be a significant contribution to the field of cell line
authentication, paving the way for more reliable and reproducible biomedical research. Our technology has the
potential to enhance the quality and reliability of biomedical research and to become a standard tool in labs
worldwide.

Public health relevance
Project Narrative Cell lines used in medical research often change over time in ways that can compromise research results, potentially leading to wasted resources and delayed drug development. This project develops a new technology that acts like a molecular "timestamp" to accurately track and verify the age and quality of cells used in research, helping ensure that scientific studies are reliable and reproducible. By improving the quality control of cell lines used throughout biomedical research and drug development, this work will accelerate the development of new treatments and therapies for various diseases.